Conformational Dynamics and Regulatory Mechanisms in the KCNH Family of Ion Channels

SUMMARY
The KCNH family of potassium channels comprise the ether á go-go related gene (ERG) channels, ether á
go-go (EAG) channels and ether á go-go like (ELK) channels. In response to changes in transmembrane
voltage, KCNH channels undergo opening and closing conformational changes to control the movement of
potassium ions across the cell membrane and dictate cell excitability. But fundamental questions have not
been answered as to the basic mechanisms of voltage-dependent gating. In this proposal we will examine the
KCNH channel voltage sensor domain (VSD) and the positively charged S4 domain helix and measure how
these domains dynamically rearrange during channel open and closing (gating). Guided by static structures,
we will use non-canonical amino acid (ncAA) technology to incorporate photoactivatable or fluorescent amino
acids into the S4 of KCNH channels. We will utilize ncAA technology with simultaneous electrophysiological
recordings to investigate channel function and photoactivation or fluorescence measurements to measure
channel structural changes. The results of our proposed experiments will show the dynamics of the
fundamental S4 motions that are a hallmark of voltage-dependent gating in KCNH (and other) channels.
KCNH channels contain novel intracellular domains, including an N-terminal Per-Arnt-Sim (PAS) domain and
a C-terminal Cyclic Nucleotide Binding Homology Domain (CNBHD). We discovered that the PAS and CNBHD
directly interact in hERG channels to regulate gating. Here we show that the PAS and CNBHD move relative to
each other during channel gating, and we will leverage ncAA methods to examine how conformational changes
at the PAS-CNBHD interface regulate voltage-dependent gating.
Distinct from other KCNHs, hERG is of extraordinary physiological importance. Two hERG isoforms (hERG1a
and hERG1b) co-assemble to form a native channel (IKr) that repolarizes the human cardiac action potential
(AP). Genetic mutations in hERG and inhibition of hERG channels by the off-target action of drugs reduce
hERG currents, leading to inherited and acquired forms of long QT syndrome (LQTS), a predisposition to
cardiac arrhythmias and sudden death. Recently, we identified a TRIO and f-actin binding protein (TRIOBP-1)
that binds the hERG C-terminus and discovered that a hERG1a/hERG1b/TRIOBP-1 complex had a functional
interaction with the voltage-gated calcium channel that was cardioprotective in stem cell-derived
cardiomyocytes. Here we will use a toolbox of methods to ascertain key interactions among the players in this
macromolecular complex and how they regulate the cardiac action potential.
Completion of these studies will lead to a mechanistic understanding of how angstrom scale dynamics
underlie gating in KCNH channels and how the mechanisms and interactions in a macromolecular complex
shape the cardiac AP. Finally, we will identify how LQT2 mutants perturb physiological and biophysical
mechanisms in hERG channels, which will lead to personalized diagnosis and treatments for human diseases.

Public health relevance
The topic of this proposal are the properties of human ether á go-go related gene (hERG) potassium channels and closely related channels, which are of extraordinary clinical importance and are directly relevant to biomedical science. This is because hERG plays a prominent role in the heart, which is emphasized by inherited mutations in hERG channels and the off-target effects of prescription drugs which reduce hERG and cause sudden death cardiac arrhythmias, which are a prevalent and serious clinical problem. Completion of these studies will lead to a greater understanding of the basic properties of hERG and related channels and are anticipated to lead to rational biomedical strategies to counteract or reverse the loss of hERG current that causes heart disease.